Cortical Mechanisms of Innate Frequency Discrimination

Abstract
Throughout evolution, the ability to distinguish acoustic frequencies from each other and from the surrounding
auditory environment has been essential for survival. In humans, this ability remains fundamental to everyday
hearing, linguistics, and musicality, yet the neural and molecular mechanisms underlying frequency
discrimination are not well understood. GABAergic interneurons (INs) in the auditory cortex (ACx) have been
implicated as the cellular loci underlying behaviors that rely on frequency-discrimination abilities. This notion has
been confirmed by the recent discovery that hyperexcitability of GABAergic INs in the ACx causes frequency-
discrimination hyperacuity in models of Williams-Beuren syndrome (WBS), a neurodevelopmental disorder
associated with cognitive and learning impairments that spares or enhances auditory functions. We recently
showed that mouse models of WBS have innately superior frequency-discrimination acuity that results from
hyperexcitable GABAergic INs in the ACx. Among the WBS genes, Gtf2ird1 is the only one whose
haploinsufficiency replicates WBS phenotypes by downregulating vasoactive intestinal polypeptide receptor 1
(VIPR1). VIPR1 deficiency causes hyperexcitability of GABAergic INs in the ACx and improves frequency-
discrimination abilities. Preliminary data indicated that VIPR1 acts through voltage-gated calcium channels
(VGCCs), but the identity of specific VGCCs is unknown. VIPR1 overexpression in those cells reverses the
cellular and behavioral phenotypes of WBS mice. This finding indicates that the VIPR1-dependent mechanism
in cortical INs underlies the mechanism of superior frequency-discrimination acuity in WBS mice. Furthermore,
this mechanism improves frequency-coding capabilities in the ACx, as evidenced by 2-photon imaging of
neuronal ensemble activities in awake mice. We surmised that we could employ the reverse-translational
approach by using these findings in a disease model to gain insights into the normal physiology of frequency
discrimination by focusing on VIPR1 signaling in cortical INs. Therefore, we propose the following hypothesis:
VIPR1 signaling in a certain subtype of GABAergic INs (PV+, SOM+, or VIP+) in the ACx underlies frequency-
discrimination abilities and frequency coding through bidirectional tuning of IN excitability via VGCCs. To test
this hypothesis, we propose 3 Specific Aims: In Aim 1, we will identify the subtype of cortical GABAergic INs in
which VIPR1 signaling regulates frequency discrimination. In Aim 2, we will elucidate the mechanistic link
between VIPR1 signaling and IN hyperexcitability in the ACx by identifying the VGCC involved. In Aim 3, we will
determine how VIPR1 signaling affects frequency coding in the ACx. The results of these experiments will
substantially advance our knowledge about the cortical mechanism of frequency discrimination.

Public health relevance
Relevance: Distinguishing acoustic frequencies is the essential function of the auditory system. Recent works indicate that GABAergic interneurons in the auditory cortex mediate frequency discrimination abilities. We recently identified vasoactive intestinal peptide receptor 1 (VIPR1) in GABAergic interneurons as a molecular target. Here we propose to elucidate VIPR1-mediated cortical mechanisms of frequency discrimination.